Administrative Core

CORE C ABSTRACT
Administrative Core
Core Leader: Charles Sawyers (MSK)
The P01 Administrative Core will provide the organizational support and leadership necessary to support the
successful accomplishment of P01 Program aims.
Core Services:
· Scientific Oversight: monitor and support progress of individual projects and convene the scientific advisory
board at regular intervals
· Financial Management: serve as the centralized P01 budgetary coordinator and financial manager
· Grants Administration: serve as administrative liaison to the National Cancer Institute, ensuring the timely
submission of all required reports and compliance with institutional and federal regulations
· Data Management: assist relevant Projects and Cores in management, distribution, and analysis of
harmonized data and monitor the Data Management and Sharing plan
· Communication: foster cross-team and core communications
· Meetings Coordination: organize all project-related meetings
The Administrative Core fulfills the following Specific Aims:
Aim 1: Use the existing AACR Project GENIE (GENIE) infrastructure to serve as central hub for data collection,
harmonization, storage, distribution, visualization, and analysis among Project and Core Teams.
Aim 2: Develop, deploy, and monitor project communications plan to ensure effective communication between
project teams and cores, the EAB and IAB, the NCI and the broader scientific community and general
public.
Aim 3: Provide centralized administrative and financial management support to monitor scientific progress, data
integrity, and budget allocation and expenditures.

Public health relevance
NARRATIVE This P01 program is multi-institutional collaboration that will purse research to enhance the implementation and practice of precision oncology. The Administrative Core manages P01 Program activities including: budget and resource allocation, data sharing pipelines, research administration, and federal agency compliance.